GTP BINDING PROTEINS AND ADENYLATE CYCLASE

Cholera toxin, the secretory product of Vibrio cholerae responsible in part for the devastating diarrheal syndrome characteristic of cholera, activates adenylyl cyclase by catalyzing the ADP-ribosylation of Gs-alpha, the stimulatory guanine nucleotide-binding protein of the cyclase system. The toxin-catalyzed reaction is stimulated, in the presence of GTP, by approximately 20 kDa guanine nucleotide-binding proteins, termed ADP-ribosylation factors or ARFs. Rabbit polyclonal antibodies against bovine sARF II reacted with soluble and membrane ARFs but did not react with several other guanine nucleotide-binding proteins. The anti-ARF antibodies reacted with approximately 20 kDa ARF-like proteins in a variety of tissues from several species. The highest levels of immunoreactivity were observed in brain and other neural tissues. In other tissues, an immunoreactive band corresponding to SARF I was present. During rat brain development, when quantified by both immunoreactivity and function, SARF II was lowest at birth, increased somewhat by 10 days, and was maximal at 27-60 days; SARF I was unchanged. The increase of SARF II protein during postnatal development was paralleled by increased ARF 3 mRNA but not by mRNAs for five other ARFs. In the presence of GTP-gamma-S, ARF and toxin formed either an ARF-CTA complex in SDS (SDS) or self-associated ARF in DMPC/cholate, which were separated from monomeric ARF and CTA by gel filtration. Substrate specificities of ARF/toxin complexes were different from those of the monomeric proteins. The ARF 3 gene contains five exons and four introns and spans 18.3 kb. Two ARF 3 mRNAs are synthesized using alternative polyadenylation signals in exon 5. The gene appears to have multiple transcription start sites, no TATA box, no CAAT box and high G/C content in 5' promotor region. The ARF 1 gene is identical to the ARF 3 except that it has only one polyadenylation signal. The organization of the ARF 2 gene is identical to those of ARFs 1 and 3, although the promoter region is somewhat different and thus regulation of ARF 2 gene transcription may differ.